Functional Response Biomarkers for Systemic Sclerosis-Associated Interstitial Lung Disease

PROJECT SUMMARY
Interstitial lung disease (ILD) is a leading cause of systemic sclerosis (SSc)-related death in the United States
and the World. ILD occurs in the majority of patients with SSc and progresses the most rapidly early in the
disease course. We have demonstrated that patients who experience SSc-ILD progression within the first two
years of their disease have an increased risk of premature mortality. Therefore, modifying the course of SSc-
ILD at this early disease stage through therapeutic intervention can improve outcomes for patients.
However, no reliable treatment response biomarkers exist for SSc-ILD to personalize therapy. Clinicians
struggle to determine whether a patient is responding to a specific therapy using existing response tools that
rely on clinical, physiologic and radiologic assessments, which are imperfect in their ability to categorize
patients who are and are not benefiting from therapy. Further, measurable changes in the existing response
tools only occur after a substantial amount of time (1 year or more) and lung damage has occurred from ILD.
Response biomarkers that signal therapeutic efficacy early in the course of treatment are greatly needed. With
the expansion of treatment options for SSc-ILD, reliable response biomarkers could guide clinicians to stop
administering an ineffective agent and start an alternative agent before the patient experiences irreversible
lung damage. Our group has demonstrated that specific circulating biomarkers, such as C-reactive protein,
interleukin-6, and chemokine (C-X-C motif) ligand 4, chemokine ligand 18 and Krebs von den Lungen 6,
decrease in response to treatment with mycophenolate mofetil (MMF) in the context of a clinical trial. A greater
decline in these biomarkers at 1 year was associated with future improvement in lung function at 2 years.
We herein propose to validate the aforementioned response biomarkers in an observational cohort of patients
with SSc-ILD and determine whether early changes (at 3, 6 months) in these and other circulating biomarkers
predict progressive pulmonary fibrosis (PPF) at 1 year. We also propose to study a novel response biomarker
for SSc-ILD: Positron emission tomography (PET) with a tracer that targets fibroblast activation protein (FAP).
Through measuring the change in pulmonary 68Ga-FAPi-46 uptake, we aim to track the evolution of fibrotic
remodeling activity in the lungs and link these changes to changes in circulating biomarkers. We hypothesize
that a panel of circulating biomarkers will predict changes in 68Ga-FAPi-46 uptake, as well as PPF at 1 year.
To test this hypothesis, we will perform biochemical and functional imaging biomarker assessments early in the
treatment course and evaluate patients for PPF at 1 year. This work will: (1) Identify circulating response
biomarkers for SSc-ILD; (2) Determine whether functional imaging plays a role in monitoring treatment
response in SSc-ILD; (3) Understand how 68Ga-FAPi-46 uptake correlates with radiologic features of ILD (e.g.,
fibrosis, ground glass, honeycombing); (4) Reveal biological pathways linked to fibrotic remodeling activity on
PET imaging. This work is not only relevant for SSc, but also for other rheumatic diseases associated with ILD.

Public health relevance
PROJECT NARRATIVE Interstitial lung disease (ILD) is the leading cause of death in patients with systemic sclerosis (SSc); while new therapies are available for SSc-ILD, patient access to these therapies is often delayed because it can take a year or more for clinicians to determine whether a patient with SSc-ILD is benefiting from a specific therapy using traditional tests. We propose comprehensive studies to identify novel blood-based and functional imaging treatment response biomarkers that can help to individualize the treatment journey for a patient with SSc-ILD. Measuring treatment response biomarkers early in the treatment course can help to ensure that patients receive the most effective therapies for SSc-ILD and avoid extensive use of medications that do not improve their health.